Investigation into the Epidemic of Unexplained Kidney Disease in Nicaragua: Understanding the Acute Clinical Scenario and Natural History of Disease in Mesoamerican Nephropathy.

Project Summary: An epidemic of severe, unexplained kidney disease in mostly young agriculture workers
emerged at least two decades ago in Central America. The epidemic now spans, geographically, from Mexico
to Panama, causing premature mortality, predominantly affecting rural, impoverished communities.
Mesoamerican nephropathy (MeN) has caused an excess of 20,000 deaths, yet its etiology remains a mystery,
and traditional risk factors for kidney disease are not risk factors for MeN. The curious disease has been
previously described as an asymptomatic, insidious chronic kidney disease (CKD) of unknown etiology that
progresses rapidly to end stage renal disease and death. However, recent studies by Dr. Fischer and team in a
Nicaraguan agriculture worker population reveal evidence of an acute clinical syndrome preceding CKD and
described for the first time AKI and acute tubulointerstitial nephritis in MeN. They also observed aggressive
progression to CKD in a subset (9%) of patients. The new, paradigm-shifting evidence about acute MeN suggests
an early, yet brief, window for clinical recognition and intervention. It also implies that early clinical markers for
severe disease could lead to targeted interventions. In this proposal, Dr. Fischer will build on this research by
leading a clinical investigation into MeN in a broader and more diverse populations. Based on a growing
understanding that MeN affects a broader community, including women children, than previously thought, she
will conduct community-based disease surveillance and establish the first community cohort of acute MeN
patients. The aims of the research are to validate a clinical case definition of acute MeN and describe the
natural history of disease with the overall goal of increasing our clinical understanding of MeN to enable
disease surveillance and to facilitate early identification, diagnostic work-up, clinical intervention, and targeted
future research. The proposed research is novel and addresses and urgent public health crisis, it and will
serve as an important avenue for her career development. Dr. Fischer's strategic and thoughtful plan will
address four career objectives through mentored research, formal courses, structured tutorials, and practical
experiences: (1) enhanced clinical understanding of tropical disease; (2) maintaining multidisciplinary, long-
distance collaborations; (3) advanced biostatistical techniques for complex data analysis and interpretation;
and (4) communicating research through writing and presentations. Together, the outlined research,
mentorship, and career enhancement will fortify the knowledge, skills, and confidence to advance and become
competitive for R01 funding. The Fogarty award will afford protected time and resources for a rigorous mentored
training period and transition to independence, as she forges long-term, international and multidisciplinary
collaborations, advances her skill-set and leadership abilities, and becomes professionally poised to develop a
research program that focus on reducing morbidity and mortality in Central America and other low-resource
regions of the world.

Public health relevance
Project Narrative I am proposing this research, entitled “Investigation into the Epidemic of Unexplained Kidney Disease in Nicaragua: Understanding the Acute Clinical Scenario and Natural History of Disease in Mesoamerican Nephropathy” in response to the emergence of a mysterious kidney disease that affects young and healthy people in impoverished communities throughout Central America. More than 50,000 people have died, and knowing more about the first signs of disease, how it progresses, and what makes certain develop severe disease more rapidly will point to ways to treat and prevent it. This important and novel research will have substantial public health impact, generate new research avenues, and complement my structured career development plan, as it becomes the foundation of my pathway to independence and success in global health research.